Administrative Core

ABSTRACT
Administrative Module
The Core Grant for Vision Research is directed by Samuel M. Wu, PhD, Professor of Ophthalmology,
Neuroscience, and Molecular Physiology and Biophysics, and the Camille and Raymond Hankamer Chair in
Ophthalmology at BCM. Dr. Wu is an established retinal neuroscientist who has extensive experience in
managing the Vision Core grant during the past 30 years. He will be assisted by a Core Grant Advisory
Committee, consisting of himself, module directors Drs. Pflugfelder, Ching-Kang Chen and Rui Chen and an
Administrative Associate, Ms. Jessica Nollkamper. The Advisory Committee will meet quarterly and ad hoc to
review the Core budget, utilization of the modules, distribution of module usage among Core investigators,
personnel matters, maintenance and service contracts, and other activities related to the Core. The entire
Core faculty will meet at least once a year to discuss Core module services, management and operational
problems. The day-to-day operation of the four Resource/Service Core modules will be monitored by Ms.
Nollkamper who will coordinate with the Director and Advisory Committee to review, approve, and process all
purchase requisitions, service contracts, financial reports, salaries and fringe benefits, and biosafety
applications and correspondence relating to the Core Grant for Vision Research. Dr. Wu and Ms. Nollkamper
will use the Vision Core internal website to track usage log books and distributions of support personnel time
and equipment usage among Core investigators, signup sheets, work orders and progress, software updates
and equipment maintenance. She will keep records on all orders, and archive the usage and job records of all
four modules at the end of each month, and will alert the module support personnel and the module director if
problems occur and/or if the expected completion date is not met. Ms. Nollkamper and the four
Resource/Service module directors will prepare a written semi-annual review and usage summery and an oral
presentation for each module at the quarterly Core Advisory Committee meetings.

Public health relevance
NARRATIVE Administrative Module The Core Grant for Vision Research is directed by Samuel M. Wu, PhD, who will be assisted by a Core Grant Advisory Committee, consisting of himself, module directors Drs. Pflugfelder, Ching-Kang Chen and Rui Chen and an Administrative Associate, Ms. Jessica Nollkamper. The Vison Core provides support and facilities which are not available or cannot be obtained through individual grants to 24 vision research investigators at Baylor College of Medicine. The facilities in the Core modules will be used to study how visual system disorders, such as retinitis pigmentosa, age-related macular degeneration, glaucoma, amblyopia and strabismus occur and to determine what neuronal and synaptic mechanisms in the visual system are responsible for the pathogenesis of these disorders.